EFFECT OF ABOLITION OF BBB OPENING ON WATER CONTENT OF ISCHEMIC BRAIN TISSUE

The effect of prevention of reactive hyperemia, which invariably follows release of arterial occlusion in areas of the brain subjected to ischemia of intensity below threshold level, was evaluated with regard to opening of the blood-brain barrier (BBB) associated with extravasation of serum proteins, and to development of ischemic brain edema. The reactive hyperemia was abolished by hypovolemic withdrawal of the blood at the time of recirculation. Such animals showed no opening of the BBB to proteins significantly reduced edema, when tested at 3 hours following recirculation, in comparison to edema in normovolemic animals subjected to similar intensity of one hour ischemia. Brain injury determined at 3 days after recirculation varied from none to moderate in cats with cevere ischemia (below 12 mg/100g/min) in which reactive hyperemia and opening of the BBB was prevented by hypovolemia, whereas the cats with similar in severity ischemia, accompanied by reactive hyperemia and extravasation of EB, revealed a frank cerebral infarction. These studies demonstrate further the significance of serum protein extravasation in the development of brain edema and with regard to severity of ischemic injury.